OPC SURVIVOR: Optimizing OroPharyngeal Cancer SURVIVORship

ABSTRACT: OVERALL
Oropharyngeal cancer (OPC) is rising in epidemic proportions, largely owing to rise in highly curable oncogenic
human papillomavirus (HPV) attributable disease. HPV-associated OPC is often diagnosed in young individuals
presenting with near normal functional status and high quality of life (QOL) at diagnosis. Standard therapy offers
excellent two- and five-year survival probability of 95% and 79%, respectively, yet at a high cost in QOL lost.
Long-term survivors risk a host of debilitating delayed adverse sequelae of therapy. Randomized trials seeking
to mitigate toxicity by reducing the intensity of systemic therapy or decrease radiotherapy dose in HPV-
associated OPC surprisingly resulted in inferior survival (e.g., RTOG-1016, HN005). Other noteworthy efforts to
optimize the therapeutic ratio (e.g., transoral robotic surgery [TORS] and highly conformal radiotherapy) still
yield significant early toxicities published extensively by the investigators, as well as numerous late symptoms
that persist or develop many years into survivorship as independent drivers of unemployment in young survivors
(under age 60) and decisional regret about cancer therapy long after cure (median 7 years survival). The
investigators have further published extensively on three distinct, but inter-related highly morbid delayed
adverse sequelae that threaten QOL and health: 1) mandibular osteoradionecrosis (ORN), 2) late radiation-
associated dysphagia (late-RAD), and 3) late lower cranial neuropathy (LCNP). To advance precision health of
OPC survivors, we must integrate these individual lines of inquiry to better describe the intersection of actionable
phenotypic presentations, trajectories, and clusters of adverse events and novel therapies to mitigate chronic
disability as adverse events evolve from early to late survivorship. The absence of well curated long-term
survivor cohorts was the stimulus for the development of the MD Anderson Oropharynx (MDA-OPC) cohort,
an active, single institution, prospective longitudinal cancer cohort. Since 2015, 1,750 OPC patients have
enrolled with interdisciplinary characterization of exposures, diagnostic/staging, treatment, disease control, and
validated clinician- and patient-reported survivorship outcomes. Survivors are in longitudinal follow-up by the
Patient-Reported Outcomes/Function (PROF) Core which has to date acquired 31,370 PRO questionnaires and
3,687 toxicity imaging studies. The MDA-OPC cohort is an unparalleled resource for integrated OPC specific
Projects focusing on delayed treatment sequelae in this rapidly growing cancer survivor population. The OPC-
SURVIVOR P01 Program Project aims to maintain and enrich MDA-OPC infrastructure, extending outcomes
data collection beyond 5-years into long-term survivorship to support three integrated Projects focused on: 1)
osteoradionecrosis (OPC-ORN), 2) cranial neuropathy (OPC-NERVE), and 3) late radiation-associated
dysphagia (late-RAD). Our central hypothesis is that clinically feasible PRO and objective measures uncover
phenotypes and trajectories of delayed cancer therapy induced adverse events for earlier detection and
mechanistically targeted mitigation strategies.

Public health relevance
NARRATIVE: OVERALL This Program of research focuses on delayed treatment sequelae of oropharyngeal cancer (OPC) which has been rising at epidemic pace for several decades. Although contemporary treatment strategies are highly effective at curing OPC, many survivors ultimately spend cancer-free years with disabling toxicities that threaten critical functions such as speaking and eating. The investigators will integrate three Projects focused on highly impactful delayed side effects including jawbone death (osteoradionecrosis), nerve loss (lower cranial neuropathy), and swallowing difficulty (dysphagia) using common infrastructure and synergistic methods of research to understand the time course, mechanisms, non-invasive testing, and treatment options to improve lifelong health and quality of life of OPC survivors.